Administrative Supplement for Training Activities to Enhance Wellness and Resiliency at UF

PROJECT SUMMARY/ABSTRACT
Participants in biomedical and behavioral sciences research training programs are at increased risk of
depression, anxiety, and suicidality compared to the general population. The proposed supplement will
support the development, implementation, evaluation, and dissemination of interventions to
longitudinally study and enhance the wellness and resiliency of trainees in the four eligible NIGMS-
funded training programs at UF.
The project will begin with focus groups to conduct a needs assessment of wellness and resiliency of
current trainees. Information from the needs assessment will be integrated into the development of a
questionnaire on trainee wellness and resiliency. This questionnaire will be distributed to all trainees to
initiate a longitudinal study of trainee wellness and resiliency throughout their training program
appointments. The project will also support the expansion of wellbeing process groups to include
predoctoral and postdoctoral trainees, and the development and deployment of resiliency workshops.
Project outcomes will be submitted for publication in peer-reviewed journals, and the resiliency
workshop materials will be made publicly accessible as Canvas LMS modules that will adhere to
section 508, CVAA, and WCAG 2.0 AA accessibility standards.

Public health relevance
PROJECT NARRATIVE College and university undergraduate students, predoctoral graduate students, and postdoctoral students, including trainees in biomedical research training programs, are at elevated risk of decreased mental wellness and resiliency, including high rates of depression, anxiety, and suicidal ideation compared to the general population. The proposed supplement will support the development, implementation, evaluation, and dissemination of interventions to enhance the wellness and resiliency of trainees in the NIGMS-funded training programs at UF. This will include focus groups for needs assessment, initiation of a longitudinal study of trainee wellness and resiliency, expansion of wellness process groups, and development of a resiliency workshop.